Research Dissemination Contract

Dissemination of NIDA Research to a variety of audiences. The contract will be designed to endure the vitality needed information on substance abuse is disseminated to members of the general public and to health care professionals.